Prevention of Chlamydia trachomatis infections: Evaluation of vaccination and post-exposure prophylactic antibiotic use as population-level strategies

PROJECT SUMMARY
The global burden of sexually transmitted infections has increased over the last several decades. In 2020
alone, the World Health Organization estimated that 128.5 million incident cases of Chlamydia trachomatis
(CT) occurred among individuals of reproductive age. Although risk of infection persists across the general
population, young women aged 15–24 years, as well as gay, bisexual, and other men who have sex with men
(MSM), have a significantly greater risk for acquiring CT. Successful interruption of CT infections and
subsequent sequalae requires the implementation of wide-scale public health prevention measures. However,
effective primary- and secondary-level prevention strategies, including prophylactic antibiotic use and vaccines,
are underutilized or unavailable. Interest in the use of doxycycline prophylaxis has grown in recent years but
concerns of antibiotic resistance in Neisseria gonorrhoea and future resistance in CT limit its feasibility and
warrant additional research on considerations for successful implementation. Given these concerns, an
effective vaccine is likely required for enduring population-level declines in CT infections. Testing of vaccines to
protect against CT infections has thus far been limited to Phase I trials and further testing is needed to
understand the efficacy and safety among broader populations. The vaccine development process could be
strengthened by parallel investigations using mathematical models and health economic evaluations to assess
the impact of a CT vaccine. This proposal addresses the following questions: Among individuals potentially
eligible for antibiotic prophylaxis, what is the frequency of, and characteristics associated with, antibiotic use
that can inform the utility of doxycycline as a preventative measure? What are the potential impacts of a
proposed CT vaccine on disease burden? Is CT vaccination a cost-effective prevention strategy compared to
current screen-and-treat practices in the United States? To answer these questions, the project will
characterize the frequency and factors associated with antibiotic use among MSM in Seattle, WA (Aim
1) using longitudinal data from the ExGen Study, a prospective cohort study of MSM. Second, a mathematical
model will be developed to predict the 50-year impact of national rollout of a theoretical vaccine on the
burden of urogenital and rectal CT infections in the United States (Aim 2). Model structure and
parameters will be sourced from peer-reviewed published literature, publicly available surveillance systems,
and vaccine target product profiles. Finally, the cost-effectiveness of CT vaccination strategies, in
combination with screen-and-treat interventions, will be compared to screen-and-treat alone in the
United States (Aim 3) using the mathematical model developed in Aim 2, alongside cost data from peer-
reviewed and public sources. This research addresses critical knowledge gaps about CT prevention strategies
and serves as a training opportunity for the applicant to develop into an independent, academic researcher.

Public health relevance
PROJECT NARRATIVE: Chlamydia trachomatis (CT) causes roughly 128 million sexually transmitted infections globally each year. There are currently few interventions to protect people from infection with CT. This project will use data from research and disease surveillance to assess the feasibility of antibiotic treatment shortly after exposure to prevent CT infection and to estimate the population-level health impacts and cost-effectiveness of a hypothetical vaccine delivered before exposure to CT.